Novel TCR transgenic mice to study tumor neoantigen-specific T cell responses

PROJECT SUMMARY
Activated CD8+ T cells are capable of responding to tumor neoantigens and can aid in the clearance of tumors.
Indeed, CD8+ T cells are critical for the beneficial effects of immune checkpoint blockade therapies, in those
patients that respond to such therapies (mAb’s to CTLA-4, PD-1/L1, LAG3). In addition, CD8+ T cells themselves
can be deployed as therapies, in the form of CAR-T cells for some hematological malignancies. Other therapeutic
or preventative modalities still under active study include expansion and infusion of tumor-infiltrating lymphocytes
(TIL) and vaccination. All of these approaches require either the presence of tumor specific CD8+ T cells whose
function can be augmented or knowledge about a tumor neoantigen that can be directly targeted therapeutically.
Despite advances, there are still significant gaps in knowledge regarding how tumor-specific CD8+ T cells are
primed, how they are recruited to (or excluded from) the tumor, and how they become dysfunctional in the tumor
microenvironment.
Our understanding of the rules of T cell development, function and antigen discrimination have been greatly
enhanced using T cell receptor transgenic (TCR Tg) mice. These models provide a traceable pool of antigen-
specific T cells that can be studied over the course of an infection. Many investigators have also taken advantage
of TCR Tg T cells to model responses to tumor antigens, by expressing the cognate antigen (e.g. LCMV GP,
OVA) in transplantable tumor lines or genetic tumor models. One of the limitations of such studies is that they
have mostly employed non-tumor antigens and their respective TCR’s, which often represent high affinity outlier
TCR-ligand pairings. There is thus a need for additional models that employ naturally arising tumor neo-antigens
and matching TCR’s.
One of the most commonly used transplantable murine syngeneic tumor lines in the C57BL/6 background is
MC38, a colon carcinoma model originally derived from C57BL/6 mice treated with methylcholanthrene. A recent
study reported the identification of a tumor neo-antigen in the MC38 model, a mutated form of the ribosomal
protein Rpl18, referred to hereafter as Rpl18*, presented by H-2Kb. We have now validated that this represents
a major T cell epitope in C57BL/6 mice bearing MC38 tumors. We have also identified TCR’s that recognize this
epitope and confirmed that these TCR’s can mediate T cell activation and effector function. We now propose to
use two of the TCR’s that we have identified to generate TCR Tg mouse lines that can be used for future study
of T cell anti-tumor responses in mouse models.

Public health relevance
Project Narrative The immune system is important for fighting off infection with bacteria, viruses and fungi and can also eliminate tumors in some individuals with cancer. One type of immune cell that plays a particularly important role in eliminating viruses, some bacteria and tumor cells is the so-called CD8 T cell. The studies described in this proposal will lead to a better understanding of how CD8 T cells respond (or not) to cancer and as such may lead to better therapies for treating cancer by identifying novels ways to enhance immune responses to cancer.